Caenorhabditis Intervention Testing Program - Data Coordination Center - Transfer from Buck Institute

Caenorhabditis Intervention Testing Program at Oregon Bridge Funding Request
Health challenges linked to human aging take a tremendous toll on society. Physical and cognitive decline limit
the quality of life for the elderly and their caregivers. Aging is the major risk factor for, and possible cause of,
cancer, diabetes, and neurodegenerative disease. Without question, the promotion of healthy aging with
extended resistance to decline and disease should be a major objective of current medical research.
Fortunately, tremendous progress has been made in the biology of aging field and the science is poised to be
translated into preclinical and clinical science. Simple animals models such as the nematode Caenorhabditis
elegans have been at the heart of this success. Many genes and chemical compound interventions that
modulate aging processes are likely to act similarly in humans. The Caenorhabditis Intervention Testing
Program (CITP) aims to capitalize upon these unique strengths to identify and robustly test a wide range of
compounds for potential life and healthspan extending effects. The CITP consists of a co-operative scientific
group involving three closely interacting laboratories who coordinately test pharmacological interventions for
their ability to extend healthy aging and promote longevity in nematodes. This application is to request bridge
funding for the highly successful Caenorhabditis Intervention Testing Program (CITP) to fill a gap between
funding cycles.

Public health relevance
Project Narrative—Health Relevance This project will identify pharmacological interventions that improve the length of life and/or the quality of aging in a simple animal model that shares many hallmark features of aging in humans. Data obtained at three assay sites by rigorously testing a genetically diverse test set is anticipated to identify chemical treatments with high potential to be efficacious in a diverse human population. Our study may lead to treatments that protect against physical deterioration, cognitive decline, and disease susceptibility in the elderly human population.